Developmental Funds

Developmental Funds support three University of Virginia (UVA) Cancer Center activifies: Faculty Recruitment, Pilot Projects, and Research Infrastructure Development. These activifies enable the Cancer Center to implement its long-term strategic goals, which depend on recruifing the best people and on supporting them, as well as exisfing faculty, to perform the highest quality cancer-focused research. The exceptional quality of the new recruits and Shared Resources, and the multiple positive Pilot Project outcomes—as measured by resulting research papers and peer-reviewed grants—all bear witness to the success of UVA Cancer Center Developmental Fund investments. Such accomplishments reflect the sound stewardship of these funds. In addifion, the success has served as a sfimulus for obtaining addifional philanthropic support for developmental activities, thus leveraging NCI dollars.

Public health relevance
RELEVANCE (See instructions): Developmental Funds provide the venture capital with which the UVA Cancer Center invests in the future of cancer research.